Regulation of Ras in development by post-translational modification

SUMMARY
Eukaryotic signaling pathways translate external cues in specific contexts into diverse biological outputs.
Proper timing and duration of a signaling response requires careful regulation of stability, trafficking, activation,
and deactivation of multiple components within a network. This overall coordination can involve positive
feedback circuits to amplify signaling and/or negative feedback circuits to constrain signaling. The Ras
signaling pathway is crucial in development to regulate proliferation, cell survival, cell fate, and patterning.
Mutations in Ras or other components of the pathway that lead to increased Ras signaling cause
developmental disorderes collectively known as “Rasopathies” such as Noonan's syndrome or
Neurofibromatosis Type 1 (NF1). Using Drosophila, we discovered that Rabex-5 (an E3) downregulates Ras
by promoting its mono- and di-ubiquitination. Specifically, we discovered that impairing Ras ubiquitination in
vivo in Drosophila led to striking effects on cell proliferation, cell survival, developmental patterning, and
organismal longevity, reflecting a role for Ras ubiquitination in development, tumor suppression, and survival.
The power of Drosophila genetics and the well-established paradigm of studying Ras in Drosophila make this
system ideally suited to characterize this phenomenon in a multi-cellular context. We more recently discovered
that Rabex-5 targeting of Ras requires an N-terminal tyrosine in Ras, Tyrosine 4 (Y4). We hypothesize that
phosphorylation of this tyrosine directs targeting of Ras by Rabex-5. Our hypothesis predicts that the
kinase(s) and phosphatase(s) that regulate modification of Y4 are crucial regulators of Ras signaling. The goal
of our application is to elucidate the role of tyrosine phosphorylation of Ras to direct its inhibitory Rabex-5-
mediated ubiquitination and maintain pathway homeostasis. Specifically, we propose to further characterize
the biological role of Y4 phosphorylation in Ras ubiquitination, to identify the Ras Y4 kinase(s) and
phosphatase(s), and to characterize their roles in regulating Ras in development.

Public health relevance
NARRATIVE Ras is a protein important in regulating patterning, cell fate, and proliferation during development, and mutations that increase signaling through the Ras pathway are frequently found in developmental disorders called “Rasopathies.” The proposed studies will elucidate a novel regulation of Ras by a process called “ubiquitination” during development to advance our understanding of how Ras signaling is regulated. This work will have profound implications for developmental biology research and may identify therapeutic points of entry for Rasopathies.